Improving Reproducibility of Respondent Driven Sampling through Adaptive Design

Respondent driven sampling (RDS) is a recruitment method for hard-to-sample populations that are
rare in number and/or elusive due to highly-stigmatized or illicit behaviors. For these groups, traditional
probability sampling rarely offers feasibility, because it requires prohibitively high screening costs to locate
eligible persons, and, even when eligible persons are located, their desire to hide produces false negatives.
Based on the premise that people of similar traits form some type of social networks, RDS exploits the existing
networks for recruitment and has been applied to numerous studies. What sets RDS apart from traditional
sampling is that the recruitment process is mostly controlled by participants themselves through their chain-
referral that asks participants to recruit other eligible persons from their networks. The use of organic social
networks for sampling is an innovative feature of RDS. This, however, comes with one major challenge. In
order to capitalize on RDS, participants need to cooperate with recruitment requests. Because of
noncooperation, the sample may stop growing in size, resulting in a project overrun. However, the lack of
attention to this noncooperation process in the literature makes RDS data collection progress extremely difficult
to predict at the design stage, and when faces with undesirable (and often unexpected) challenges,
researchers are forced to make unplanned design changes (e.g., offering larger incentives) on the spur of the
moment in hopes of making RDS “work”. Additionally, noncooperation leads to a violation of a critical
assumption of RDS inferences. In sum, the current practice of RDS lacks operational and statistical
reproducibility, making its scientific integrity questionable.
This study attempts to improve reproducibility of RDS by proposing Adaptive-RDS (A-RDS) as a design
framework and to provide practical tools on which researchers rely for successful implementation of RDS and
by developing A-RDS specific design guidelines and software that will allow monitoring RDS data collection
progress and improve inferences that closely mirror the true data generation process. Under A-RDS, we will
plan design adaptation strategies, including indicators and rules for adaptations prior to the data collection.
During the field work, instead of assuming the same recruitment cooperation patterns across participants, we
will predict individual-level cooperation propensities from incoming data and tailor the number and type of
coupons for each participant received based on the pre-specified rules. For doing so, data collection progress
will be closely monitored and used for making adaptation decisions. In particular, this approach is empirically
applied to PWID studies to provide data for addressing rapidly escalated issues with opioid use.
By providing a practical yet data-driven, rule-based tool to the research community, the proposed study will
boost researchers' control on the operations of RDS, leading to not only improved reproducibility but also
increased chances of meeting critical assumptions in RDS required for valid inferences.

Public health relevance
NARRATIVE Respondent driven sampling (RDS) was developed in response to rapidly increasing data needs for populations that are rare in number and/or elusive due to highly-stigmatized or illicit behaviors, such as persons who inject drugs and recent immigrants. While RDS has been applied to numerous public studies, such as the National HIV Behavioral Surveillance by CDC, the current practice lacks operational and statistical reproducibility. This project aims to examine Adaptive RDS (A-RDS) as a design framework in order to improve reproducibility and to provide tools on which researchers rely for successful implementation and analysis of RDS.